MISOPROSTOL EFFECTS ON BLOOD PRESSURE CHANGES IN ESSENTIAL HYPERTENSION

This study will determine whether misoprostol will attenuate the rise in mean blood pressure for diclofenac sodium in elderly, salt sensitive stage I-II patients with essential hypertension.